Optimizing the integration between human and digital support in a meditation app for depression and anxiety

Project Summary / Abstract
The United States is experiencing a mental health crisis and most individuals who could benefit
from treatment do not receive it. Mobile health (mHealth) technology has the potential to reduce
the public health burden of depression and anxiety, two extremely common mental illnesses.
Meditation apps are by far the most widely used mental health apps, but they are plagued by low
rates of engagement and modest effect sizes relative to human-delivered interventions. The
addition of small amounts of instructor support and digital prompts may increase the effectiveness
of meditation apps while retaining the efficiency and scalability of the mHealth delivery format.
There is a need for careful, programmatic research examining the effects of these components
and identifying for whom and when they may be most beneficial. The proposed study will begin
addressing this gap through a hybrid factorial and micro-randomized trial (MRT) to optimize
augmentation of the Healthy Minds Program (HMP), a widely-used meditation app with promising
empirical support. Participants downloading HMP with clinically elevated symptoms of depression
and/or anxiety (n=688) will be randomly assigned via a 2X2X2 factorial design to one of eight
conditions crossing introductory coaching (yes/no), on-demand email-based coaching (yes/no), and
digital prompts (yes/no). Those in the digital prompts condition will be further micro-randomized
daily via a MRT to receive or not receive a digital prompt encouraging them to engage with HMP.
Psychological distress (composite of depression and anxiety) will be assessed at baseline, over the
4-week intervention period, and at 6-month follow-up. Key candidate mechanisms linking instructor
support and digital prompts with outcomes will also be assessed. Aim 1a will evaluate the effect of
introductory coaching, email-based coaching, and digital prompts on month 6 psychological
distress (primary outcome) and candidate mechanisms (therapeutic alliance, HMP engagement).
Aim 1b will identify baseline characteristics that moderate the effects of these components. Aim
2a will investigate whether receiving (vs. not receiving) a digital prompt on a given day reduces
proximal (same day) psychological distress and daily HMP engagement. Aim 2b will investigate
whether the proximal effects of receiving (vs. not receiving) a daily digital prompt are moderated
by baseline and time-varying information. Aim 3 will examine whether therapeutic alliance and
HMP engagement mediate the effects of introductory coaching, email-based coaching, and digital
prompts on month 6 psychological distress. The proposed research will result in an optimized
version of HMP that can be implemented at scale. Results will also clarify who is most likely to
benefit from these components and under what conditions just-in-time prompting is most beneficial.

Public health relevance
Project Narrative The proposed project seeks to benefit public health by augmenting a widely-used, evidence- based, 4-week meditation app (Healthy Minds Program [HMP]) through the addition of small amounts of instructor support and digital prompts and examining effects on psychological distress (composite of depression and anxiety) among new users of HMP with clinically elevated symptoms of depression and/or anxiety. Ultimately, this line of research is aimed at increasing access to optimized digital interventions that can be used to decrease the public health burden associated with depression and anxiety in ways that are both effective and resource efficient. The current study will evaluate the addition of three candidate components (introductory coaching, on- demand email-based coaching, and digital prompts); identify who is most likely to benefit from these components and under what conditions just-in-time prompting is most beneficial; and test key candidate mechanisms linking these components to improvements in psychological distress.